Administrative and Database Management

Core B is as an administrative and database management core that will serve all four projects. This core will provide two vital functions which are essential to the research program. First, the core will provide program- specific administrative support including coordinating interactions between projects, organizing regular monthly meetings of all the project leaders and personnel, overseeing expenditures, and organizing all scientific advisory board meetings. The second main function of this core is to generate and maintain a web database for entry and compilation of data on cell populations in different tissue sites by all project groups by customization using Chemcart